Retinoic Acid Induced Lymphangiogenesis for Post-Surgical Lymphedema

Lymphedema is an incurable condition characterized by lymphatic obstruction, tissue swelling,
immune dysfunction, and fibrosis after lymphatic injury. Lymphedema affects 5 million Americans and
is associated with poor quality of life due to extremity disability, disfigurement, and risk for recurrent
limb-threatening infection. In the US, lymphedema is most commonly a consequence of lymph node
dissection for the treatment of solid tumors such as breast or pelvic cancer. Despite the fact that
lymphedema is common and morbid, there are currently no effective drug treatments. Using
preclinical rodent models of lymphedema, we have shown that 9-cis retinoic acid (RA) significantly
accelerates lymphatic regeneration following injury, restores functional lymphatic drainage, and
prevents development of lymphedema. Our overarching hypothesis is that RA-mediated
lymphangiogenesis is a promising therapy for secondary lymphedema. The objective of this proposal,
which is the first logical step towards implementing this treatment clinically, is to increase our
understanding of the mechanisms by which RAs regulate lymphangiogenesis and develop a
translational framework for the use of these compounds. The specific aims of this proposal include
Aim 1: Determine how RA selectively induces lymphangiogenesis; Aim 2: Elucidate the roles of FGFR
and VEGFR signaling in RA-mediated lymphangiogenesis; and Aim 3: Use early biomarkers of
lymphatic insufficiency to develop a predictive model that can guide initiation of RA therapy. Based
on the current lack of effective therapy, it is clear that there is a need to develop an etiology-focused
treatment for post-surgical lymphedema. The proposed studies will address important mechanistic
questions regarding RA mediated lymphangiogenesis and also develop an early biomarker based
predictive model that will guide treatment windows for RA therapy. The proposed work will
significantly improve our understanding of RA-mediated lymphangiogenesis as well as support clinical
translation of a RA as a preventative treatment regimen for post-surgical lymphedema.

Public health relevance
Lymphedema is an incurable condition that affects over 5 million individuals in the US and is characterized by tissue swelling after lymphatic node injury or resection. There is no pharmacologic therapy that is currently approved to prevent post-surgical lymphedema. Our laboratory has shown that retinoic acid therapy mitigates lymphedema after surgical injury by promoting lymphangiogenesis in multiple pre-clinical models. The objective of this proposal is to increase our understanding of the mechanisms by which retinoic acids regulate lymphangiogenesis and develop a translational framework for the clinical use of these compounds.